High-resolution Genetic Mapping of Maternal Effects and Epistatic Suppressors of Congenital Heart Disease Risk

PROJECT SUMMARY / ABSTRACT Congenital heart disease (CHD) is the most common congenital anomaly, which leads to significant morbidity and mortality in newborns. Although great surgical advances have reduced CHD mortality in newborns and children, these patients are not cured. Many of these children grow up and experience serious morbidity and truncated lifespans as adults. It has become evident that we need strategies to move our efforts away from intervention and toward prevention. The first step in this endeavor is to understand the causes of CHD. Surprisingly, environment and mutations are estimated to explain less than one-third of CHD cases. In many cases, however, even when a vital cardiac gene is mutated, a heart defect does not occur. This highlights the critical role that genetic modifiers have in CHD pathogenesis. Attempts to identify these modifier genes have had marginal success in humans. This motivated us to look toward animal models, in which we can control the effects of environment and genetics. Our mouse model replicates CHD risk in susceptible people through a heterozygous mutation in Nkx2-5, an essential cardiac transcription factor. We then use inbred strain crosses and quantitative genetic methods to identify genetic polymorphisms that modify CHD risk in Nkx2-5+/- mice. Through this model system, we inadvertently confirmed observations in humans that the offspring of older mothers have an elevated risk for CHD even after ruling out aneuploidy. We also determined that this risk is due to factors within old mothers, not old eggs. Remarkably, voluntary exercise for the aging mother is sufficient to reduce CHD risk to baseline levels. Subsequent studies demonstrated that the magnitude of the maternal aging risk varied according to the genetic background of our mice. This indicates that the age risk is a quantitative trait that regulates maternal factors, which can either inflate or suppress the risk of CHD. In separate experiments focused on risk modifiers within susceptible individuals, I discovered genetic loci that act as epistatic suppressors of CHD risk in multiple mouse populations. If we were able to identify the genes responsible and mimic the effects of maternal exercise or protective genetic loci, we could translate these benefits to the general population. Our past experiments were not designed to detect individual genes. So instead of speculating about the genes responsible for the maternal age- associated risk and epistatic suppression of CHD, we have chosen a prudent and unbiased approach to identify these genes. We have partnered with the laboratory of James Cheverud to use a high-resolution, advanced intercross mapping population to identify CHD modifier loci to nearly single-gene resolution. This study will be the first to map novel genes and variants that modify CHD risk at high-resolution, and these results will serve as a springboard for future research into congenital heart disease prevention. We propose these specific aims: AIM 1: Identify high-resolution genetic loci that modify the maternal age-associated risk of CHD. AIM 2: Map high-resolution genetic loci and detect epistatic suppressors of CHD risk in the offspring.

Public health relevance
PROJECT NARRATIVE Congenital heart disease (CHD) is the most common congenital anomaly, which leads to significant morbidity and mortality in newborns. It is known that the majority of CHD risk is genetic, but it has been difficult to identify these genes in humans. Previous studies in our mouse model have shown that genetic variation within both the mother and offspring influence the risk of CHD. This research project will utilize high-resolution genetic mapping to identify candidate gene-modifiers of CHD risk in a mouse model. The genes we identify in this study may eventually become therapeutic targets that reduce CHD risk in susceptible families.